Deconstructing the molecular and cellular mechanisms of psoriatic arthritis pain by an improved animal model

Abstract
Psoriasis (Ps) is an autoimmune-mediated systemic inflammatory skin disease. Approximately one-third of Ps
patients eventually develop psoriatic arthritis (PsA). PsA is one of the most common forms of arthritis, impacting
around 1 million individuals in the US. Mechanical pain associated with PsA in joints and skin, triggered by joint
loading, movement, and skin touch, is a leading cause of hospitalization for patients and represents a serious
unmet medical need. Current PsA therapeutics, including recently developed interleukin 17 (IL17), interleukin 23
(IL23), and Janus kinase (JAK) inhibitors, only offer partial relief from pain. Furthermore, these treatments prove
ineffective for some individuals and have side effects. Therefore, there exists a pressing need to identify new
targets for PsA pain. Animal pain models can facilitate the rational discovery of novel analgesics. Although
current animal models of PsA have advanced our understanding of PsA pathogenesis, it is unknown if they can
be used for studying PsA pain because pain has not been characterized in any of these models. Importantly,
most of them have limitations that hinder their use for studying chronic PsA pain. We propose to improve,
characterize, and validate a mouse mannan model for PsA pain (Aim. 1). Due to the lack of animal models, we
know little about the mechanisms underlying PsA pain. Emerging evidence demonstrated that the systemic and
local tissue levels of lysophosphatidylcholine (LPC), a proinflammatory mediator and the most abundant
systemic phospholipid in humans, are elevated in psoriatic patients, suggesting its potential involvement in the
pathogenesis of PsA pain. Using our improved and validated mouse model in Aim 1, we will examine whether
elevated LPC contributes to PsA pain (Aim 2). Our previous work and preliminary data demonstrated that LPC
can activate primary sensory neurons, joint chondrocytes, and skin keratinocytes via a mechanosensitive ion
channel TRPV4. These findings prompted us to ask whether LPC drives PsA joint and cutaneous pain via TRPV4
in sensory neurons, chondrocytes, and keratinocytes (Aim 3). Success completion of this project will lead to the
development of the first animal model of PsA pain that can be used to substantively advance our understanding
of PsA pain mechanisms. In addition, this project will pave the way to identify LPC and TRPV4 as mechanistic
therapeutic targets with exciting potential to mitigate PsA pain.

Public health relevance
Modified Public Health Relevance Section Psoriatic arthritis (PsA) patients report significant disability due to joint and cutaneous pain. In this project, we aim to develop a new animal model for PsA pain and employ this model to determine whether elevated levels of lysophosphatidylcholine (LPC), a bioactive lipid, contributes to PsA pain. Success of this project may open new doors for the development of novel and effective methods to treat PsA pain.